In vivo persistence and immuno-pathogenesis of Mycobacterium abscessus in a new Xenopus tadpole model

Owing to its increasing prevalence, persistence, multidrug resistance, pathogenicity and treatment
challenges, the non-tuberculosis mycobacterium (NTM) Mycobacterium abscessus (Mab) has become a
serious threat to humans with chronic lung diseases such as bronchiectasis and cystic fibrosis, as well as
immunocompromised patients. However, Mab is still understudied compared to other pathogenic
mycobacteria. In addition, there is a limitation in current animal models that poses a real challenge for
investigating the respective roles of two Mab morphotypes, smooth (S) and rough (R), in lung
immunopathology, persistence and host immune response. The clearance of Mab in immunocompetent and
even immunocompromised mice prevent the study of chronic infection, and while for zebrafish embryos are
instrumental for investigating Mab infection, they cannot be used to model a pulmonary infection and T cell
involvement. Thus, there is a need for complementary animal models. Since like zebrafish embryos, X. laevis
tadpoles are transparent, allowing visualization of pathogen dissemination, but that in addition they do have
functional lungs and exhibit an immune system including T cells remarkably similar to humans, we propose to
develop a X. laevis tadpole model of Mab infection that mimics human pulmonary disease. Relying on an
established comparative biology approach to study immunity to mycobacteria in tadpoles and our recent
demonstration that both S and R Mab morphotypes readily infect tadpoles, disseminate in tadpole lungs and
persist up to 50 days, the objective of the exploratory research proposal is to investigate in vivo for over 40
days Mab persistence, and immuno-pathogenesis. Specifically, to address the hypothesis that persistent R
Mab is more actively proliferating and immunopathogenic than S Mab in X. laevis tadpoles we propose:
, by comparing
the host immune response and persistence of R and S Mab in the lung and other tissues using intravital
(1) Characterize immune-pathogenesis in tadpole lungs during persisting Mab infection
microscopy flow cytometry and transcriptomics as well as fluorescently labeled Mab and transgenic tadpoles
with fluorescent macrophages.
(2) Investigate the relevance of S to R morphotype switch in vivo for pathogenesis and persistence
, by
using a promoter system to control the S to R switch following infection and examining effect of switches on
persistence, pathogenicity and host immune response.
(3) Investigate genetic determinants of Mab immune-pathogenesis
, using selected Mab deletion
mutants generated by allelic exchange of Mab-specific genes as well as gene homologs shared by Gram-
negative lung pathogens.
We anticipate that novel insights relevant to human will be gathered. Our collaborative team is uniquely
positioned to carry these studies due to our background and complementary expertise.

Public health relevance
NARRATIVE Mycobacterium abscessus has become an important respiratory pathogen that is increasingly infecting human immunocompromised or with chronic lung diseases such as cystic fibrosis, and that is often refractory to antibiotic therapy. The purpose of this study is to use an alternative amphibian animal model similar to zebrafish but with lungs and functional adaptive immunity to better understand the chronic persistence and immune pathology of this pathogen.